BCM/TSU P20 Collaborative Union for Cancer Research, Education and Disparities (CURED) Collaborative Cancer Research Education Program (C-REP)

CURED C-REP Summary/Abstract
The Collaborative Cancer Research Education Program (C-REP) of the Baylor College of Medicine (BCM)/ Dan
L Duncan Comprehensive Cancer Center (DLDCCC) and Texas Southern University (TSU) P20 Collaborative
Union for Cancer Research, Education and Disparities (CURED) project will train 20 TSU underrepresented
minority students in cancer research, cutting edge technologies, and career pathway. The cohort of 20 CURED
scholars will participate in an 8-weeks mentored cancer research experience that integrates BCM and TSU
infrastructures every summer followed by year-long culturally congruent outreach education activities that will
increase the awareness, knowledge, and understanding of research, concepts, processes, and careers in cancer
research/cancer health disparities. The goal of our proposed CURED C-REP is to promote novel and effective
venues to attract URM students into biomedical research and career pathways, specifically in cancer, and to
promote comprehensive outreach education focused on cancer disparities and community engagement that will
benefit the students, faculty, and staff at both comprehensive cancer centers and ISUPSs as well as the
community. We are certain that the proposed CURED C-REP will enhance cancer research education capacity
at TSU, promote the diversity of the cancer research workforce, improve BCM/DLDCCC’s effectiveness of
developing and sustaining research programs focused on cancer health disparities while increasing the number
of investigators conducting cancer health disparities research.

Public health relevance
CURED C-REP Project Narrative The CURED C-REP will provide an 8-weeks mentored cancer research experience that integrates Baylor College of Medicine (BCM) and Texas Southern University (TSU) infrastructures every summer followed by year- long culturally congruent outreach education activities that will increase the awareness, knowledge, and understanding of research, concepts, processes, and careers in cancer research/cancer health disparities a cohort of 20 underrepresented minority students from TSU. The proposed CURED C-REP will enhance cancer research education capacity at TSU, promote the diversity of the cancer research workforce and improve BCM’s effectiveness in developing and sustaining research programs focused on cancer health disparities.